Determining the ultrastructural differences between dually and singly innervated dendritic spines and their changes following glutamate excitotoxicity using Cryo-Electron Tomography

PROJECT SUMMARY
Glutamate excitotoxicity causes neuronal apoptosis and necrosis in a myriad of age-associated neurologic
conditions such as stroke and Alzheimer’s disease. High dose glutamate stimulation of neurons causes a rapid
loss of dendritic spines (DS), membranous protrusions that bud off dendrites. DS are critical for learning and
memory, but the structural changes that result in this loss remain poorly understood due to their small size. Up
to 10% of DS are dually innervated with inhibitory synapses (DiDS) and found to be more stable than singly
innervated DS (SiDS) containing only an excitatory synapse. A process termed compartmentalization is also
considered key to DS stability, whereby mature spines with large heads and narrow necks restrict molecules
and ions from diffusion into and out of the dendrite. Recent evidence suggests an actin diffusion barrier within
the DS neck and head-neck junction could be key to compartmentalization, but this remains poorly
understood. Following excitation calcium influx causes actin network remodeling that drives DS morphologic
change. Inhibitory synapses on DiDS have been found to dampen excitatory post synaptic potentials and
calcium influx, and upwards of 86% contain a spine apparatus. Based on these findings, I hypothesize
following glutamate excitotoxicity DiDS maintain a more stable DS structure than SiDS. To investigate I
will use high resolution cryo-electron tomography paired with correlative fluorescence to compare DiDS and
SiDS and elucidate structural changes that result in DS loss following glutamate excitotoxicity. Aim 1 will
determine the ultrastructural differences between DiDS and SiDS actin networks under normal conditions. Aim
2 will determine the ultrastructural changes that occur between DiDS and SiDS following glutamate
excitotoxicity. If successful, this project would determine what high resolution structural differences exist
between DiDS and SiDS and whether DiDS are more stable following excitotoxic shock. This would also
provide investigators of excitotoxicity high resolution structural evidence for why inhibitory synapses could be
therapeutic targets to prevent neuronal injury.

Public health relevance
Project Narrative My proposal aims to use cryo-electron tomography and correlative fluorescence microscopy to elucidate the high-resolution structural changes that lead to excitotoxic loss in dendritic spines (DS). I hypothesize following glutamate excitotoxicity dually innervated DS that contain both an inhibitory and excitatory synapse have a more stable DS structure than single innervated DS containing only an excitatory synapse. If successful, this project would determine the high-resolution actin network differences between dually and singly innervated DS and provide evidence for the protective effect of inhibitory synapses on DS structure ensuing excitotoxicity.